Artifacts as Windows to Other Minds: Social Reasoning In Typical and ASD Children

DESCRIPTION (provided by applicant): Children grow up in environments saturated by human-made objects. These artifacts are crucial to our lives not only as tools, but also as an ever-present source of social information: Adults form quick and accurate judgments about another person's traits, interests, and social affiliations simply from the artifacts they own, wea and carry. Yet in spite of the role artifacts play in providing social information in adulthood, th cognitive and developmental bases of social reasoning from artifacts remain unexplored. The proposed research aims to characterize the development of artifact-based social reasoning, in both typically-developing (TD) children and children with Autism Spectrum Disorder (ASD). Through two specific aims, the proposed experiments will explore the development of reasoning about (1) shared interests and (2) shared social history on the basis of artifacts. In the first study, TD and ASD participants will be shown four characters, and an artifact owned by each. The overall functional and perceptual similarity of pairs of these artifacts will be manipulated in order to determine whether children use such similarity to infer shared interests of the characters, and whether they rely on simple heuristics or more complex reasoning processes to do so. A second experiment will examine a more complex inference (shared social history), asking whether TD and ASD children infer that social transmission has occurred when two individuals coincidentally create similar non-functional (decorative) features. In this study, participants will be shown that two people created an artifact with the same features. By specifically manipulating whether the tool's features are seen as decorative or functionally necessary, this design will determine whether and when children draw conclusions about social transmission and shared social history, and do so through high-level reasoning processes, not similarity-based heuristics. The proposed studies are complementary, and provide a low-risk entry point into a novel and important domain. Each specific aim will first test adults and TD children, then compare a matched sample of children with ASD, to determine whether the social difficulties of children with ASD may be in part due to deficits in artifact-based social reasoning By explicitly understanding artifact-based reasoning processes and identifying deficits in the ASD population, this work may lead to new, effective intervention programs to help ASD individuals use information from artifacts to identify appropriate social partners and conversation topics of mutual interest. In addition, the proposed studies will make a significant contribution t our understanding of social cognitive development by characterizing the cognitive processes underlying this social reasoning, and by opening for exploration further questions regarding children's use of social cues from artifacts in their everyday lives.

Public health relevance
PUBLIC HEALTH RELEVANCE: Adults infer crucial social information from the artifacts others own or create, like a person's interests and affiliations; however the developmental trajectory and cognitive basis of such reasoning is unknown. The proposed project will elucidate when and how typically-developing children and children with Autism Spectrum Disorder draw social inferences from artifacts, and how sophisticated such reasoning is. Understanding how children infer social information from artifacts and identifying impairments in ASD may lead to the creation of novel interventions, to help children with ASD identify appropriate social partners and conversation topics of mutual interest. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Children grow up in environments saturated by human-made objects. These artifacts provide an ever- present source of social information: Based solely on the artifacts others own, wear and carry, adults form quick and accurate judgments about a person's traits, interests, and social affiliations (e.g. Gosling, 2008; Naumann et al., 2009). Social cues from artifacts serve as implicit social glue, providing a foundation for smooth social interaction by identifying others with similar interests and social identities. Early social cognition lays a crucial foundation for learning, and failure to understand one's social environment leads to significant impairments, as in the case of Autism Spectrum Disorder (ASD, Frith, 2008). Yet in spite of the significant role artifacts play in providing social information in adulthood, the cognitive and developmental bases of artifact-based social reasoning remain unexplored. In the proposed research, I aim to characterize the development of social inferences from artifacts in typically-developing (TD) children and children with ASD, building on an extensive literature on children's reasoning about artifact design and function. Through two specific aims, the proposed experiments will explore the development of reasoning about (1) shared interests and (2) shared social history on the basis of artifacts, testing specific hypotheses regarding (a) the types of cognitive processes which underlie these social inferences (explanation-based reasoning or heuristics); and (b) the features of artifacts which provide social information (functional or non- functional/ decorative). For each Aim, I will first test adults and TD children, then compare a matched sample of children with ASD to identify deficits and delays, and determine whether the social difficulties of children with ASD may in part be due to deficits in artifact-based social reasoning. Specific Aim 1: Characterize artifact-based reasoning about shared interests in TD and ASD. People who own artifacts used for the same activity are likely to engage in or enjoy that activity. Do TD and ASD children make this inference, and if so, on what basis? We hypothesize that TD children use explanation- based reasoning, inferring others' interests as an explanation for ownership (Lipton, 2004; Tenenbaum et al., 2006). In this case, children should infer that two people have a shared interest when they own artifacts with similar functions, not just similar perceptual features. Secondly, when an alternative explanation for ownership exists, children should no longer infer that owning the same artifact indicates shared interests. Alternatively, children may use simple similarity-based heuristics, leading to specific, revealing errors when conceptual information conflicts with perceptual similarity. We propose to test adults and children at age 4-7 years, when literature suggests this reasoning is likely to emerge. Using two pairs of characters who each own an artifact, and three within-subject conditions, we first contrast ownership of overall similar vs. distinct artifacts; then pit functional and perceptual similarity against one another. In a third condition, we provide an alternative explanation for ownership. In each condition we ask an experimental question, "Which two children like to do the same activities (this pair or that pair)?", and a control question, "Which two children have the same colored eyes (this pair or that pair)?" By analyzing whether and when children choose the characters with functionally similar artifacts at a rate higher than expected by chance, these data allow us to tease apart the above accounts of the cognitive processes and features driving social inferences, and characterize specific differences between TD and ASD populations. Specific Aim 2: Characterize artifact-based reasoning about social history in TD and ASD. The tendency to create artifacts with non-functional, decorative features is universal and ancient in human culture (Dissanayake, 2000). Unlike functional features, decorative properties are arbitrary, allowing for a wide range of unconstrained choices. Because of this, when two individuals create the same complex, decorative design, the idea has nearly always been socially transmitted rather than arising twice independently. Thus, adults infer that two people who create the same decorative feature are more likely to know one another, while two people who create the same functional feature may have done so independently to solve the same problem. Do TD and ASD children infer that two people are likely to know each other when the two individuals coincidentally create the same non-functional feature? In a second experiment, I use a 2x2 design to manipulate whether a tool's feature is seen as decorative or functionally necessary, then show participants that two people created an artifact with that same feature, asking experimental questions ("Do you think [these two people] know each other?") and control questions as in Aim 1. If children use explanation-based reasoning, they should infer that the two people know each other more frequently when they create the same decorative feature vs. the same functional feature (even for the same perceptual stimuli). If participants instead use similarity-based heuristics, they should judge that the people know each other at equal rates in all conditions, since their artifacts are always equally similar. These data will thus allow us to test hypotheses regarding the cognitive processes and features driving a more complex social inference, and characterize specific differences between TD and ASD populations.